Mkp-1 suppresses immune checkpoint protein PD-L1 to prevent sepsis-associated immune dysfunction and mortality

Sepsis patients often develop cytokine storms in the early phase, and immunoparalysis associated with lymphocyte apoptosis in the later phase of illness. The majority of sepsis-related deaths occur during this secondary hypo-immune state, often due to a failure to clear pathogens. Recent studies have implicated lymphopenia as an important component in the pathogenesis of sepsis-associated immunoparalysis. A prospective cohort study found that monocyte programmed death-ligand 1 (PD-L1) expression was associated with increased risk of mortality in septic patients. PD-L1 is an immune checkpoint protein. PD-L1 engagement with programmed cell death protein 1 (PD-1), also an immune checkpoint protein, on T lymphocytes can lead to lymphocyte apoptosis. Studies in animal models of sepsis have shown that blockade of PD-1 or PD-L1 attenuates lymphocyte apoptosis, alleviates organ damage, reduces bacterial burden, and decreases mortality. Mkp-1 is a negative regulator of both p38 and JNK, and serves to restrain the production of both pro- and anti- inflammatory cytokines (e.g., TNF-α, IL-6, and IL-10). In an E. coli-induced sepsis model, Mkp-1 knockout (KO) mice exhibit features of severe sepsis, including substantially enhanced cytokine storm, exacerbated organ damage, increased mortality, and elevated bacterial burden relative to wildtype (WT) mice. Septic Mkp-1 KO mice also exhibited increased mortality relative to septic WT mice in a cecal ligation puncture model. Notably, a clinic study has found that MKP-1 expression is suppressed in septic patients, highlighting the clinical relevance of the Mkp-1 KO mouse model of sepsis. While studies in our laboratory and by others suggest that excessive IL-6 and IL-10 in Mkp-1 KO mice are, at least partially, responsible for the compromised bacterial clearance, the mechanisms remain unclear. Recently, we have found that PD-L1 expression in E. coli-infected Mkp-1 KO mice is substantially higher than that in similarly infected WT mice. Moreover, PD-L1 expression is tightly correlated with IL-6, IL-10, and STAT3 expression. While PD-L1 can be induced by IFNs via the JAK/STAT pathway, type I & II IFN mRNA were barely detectable. Since IL-6 and IL-10 also regulate the JAK/STAT pathway, we postulate that in the later stage of sepsis IL-6, IL-10, and perhaps also circulating IFNs up-regulate PD-L1 expression via the JAK/STAT pathway. We further hypothesize that over-produced IL-6 and IL-10 or IFNs in septic Mkp-1 KO mice compromise immune defense by potentiating lymphocyte apoptosis via augmenting PD-L1 expression, ultimately increasing bacterial burden and mortality. In this proposal, we propose two Aims to test these hypotheses. Aim 1 will assess whether PD-L1 neutralizing antibody decreases bacterial burden and mortality in septic Mkp-1 KO mice. Aim 2 will assess whether IL-6 and IL-10 enhance PD- L1 expression and if JAK inhibitors attenuate PD-L1 expression, decrease bacterial burden, and increase animal survival in septic Mkp-1 KO mice. Successful completion of the Aims will reveal the mechanisms underlying PD-1 induction, and uncover a novel mechanism by which Mkp-1 protects immune competence.

Public health relevance
Project Narrative Sepsis, a common cause of morbidity and mortality, is associated with cytokine storms and subsequent immunoparalysis. In an experimental model of sepsis, Mkp-1 knockout mice exhibit many features of septic patients, including excessive cytokine storm, immune dysfunction, and substantially elevated mortality. This project will delineate the role of immune checkpoint protein PD-L1 in the immune dysfunction of septic Mkp-1 knockout mice and the molecular mechanisms by which Mkp-1 protects immune competency.